THE CONTRACTOR WILL SUPPORT THE NIDA SUMMER RESEARCH INTERNSHIP PROGRAM BY PROVIDING LOGISTICAL SUPPORT TO MANAGE REIMBURSEMENT OF AUTHORIZED EXPENSES

The National Institute on Drug Abuse Summer Research Internship Program supports undergraduate students with a focus on increasing underrepresented populations in drug abuse and addiction research. Through this program, students age 18 years and older are introduced to the field of drug abuse and addiction research by participating in research internships with NIDA funded scientists at universities across the United States. Students work with leading scientists for eight weeks during the summer. The internship may include laboratory experiments, data collection, data analysis, formal courses, participation in lab meetings, patient interviews, manuscript preparation, and literature reviews. In addition, it is expected that each intern will deliver a formal presentation on their research project at the end of the internship.